Project 3: The role of sex in ART-associated changes in trophoblast behavior and epigenetics

Project 3: Project Summary
During pregnancy, sexual dimorphism can be seen throughout gestation. Sex-specific gene expression
differences are present in the preimplantation embryo, and term placenta show differences in the
transcriptome, the epigenome, histopathology and function. Sex-specific differences in adverse perinatal
outcomes have also been observed - male fetuses are at increased risk for certain perinatal complications and
more susceptible to some periconceptional and in utero exposures. Consistent with this data, we and others
have found sex-specific differences in phenotype and outcome after exposure to specific assisted reproductive
technologies (ART) interventions. Most recently, we demonstrated increased susceptibility of male human and
mouse placentas to epigenetic perturbation following embryo vitrification. These findings have led us to
hypothesize that sexually dimorphic trophoblast behavior and altered ART phenotypes occur due to the early
effects of sex chromosome complement and sex steroids on the placental epigenome and transcriptome.
However, our ability to study the cells and factors that control early pregnancy is limited by a lack of in vitro
models available to study the early events of human placentation, which includes placental trophoblast
differentiation, and trophoblast invasion. In this project, we propose using two innovative in vitro models
capable of quantifying changes in trophoblast function and epigenetic and transcriptomic perturbations, to carry
out a thorough examination of the sex-specific impact of ART interventions on early pregnancy. Specific Aim 1
will use an organ-on-chip device that recapitulates the maternal-fetal interface to examine how sex
chromosome complement and sex hormones regulate trophoblast invasion. We will also examine how this
regulation is affected by two ART-associated interventions, changes to the maternal hormonal environment
and oxygen concentration. In Specific Aim 2, using induced pluripotent stem cell lines derived from control and
ART placenta, we will examine how sex impacts trophoblast differentiation, and the effect of ART and ART-
associated exposures on this process. These studies will leverage emerging, paradigm-shifting technologies to
explore the impact of sex on early pregnancy, a time-point that has so far been inaccessible. Results from the
proposed experiments will greatly advance our understanding of sexually dimorphic processes during
placentation and further our knowledge of the pathways involved in sexually dimorphic responses to ART
exposures, allowing us to modify protocols and develop interventional strategies to reduce adverse outcomes
that lead to significant morbidity and mortality in both mother and child.